Islet & Physiology Core

ABSTRACT (ISLET & PHYSIOLOGY CORE)
The Islet & Physiology Core supports the overall mission of the Indiana Diabetes Research Center (IDRC) to
foster collaboration, support training, and promote cutting edge research in diabetes and related metabolic
disorders by providing comprehensive and state-of-the art services in rodent islet isolation; zebrafish, rodent,
swine, and human islet characterization; human, rodent, and swine islet transplantation; and rodent metabolic
phenotyping. The Islet and Physiology Core supports the work of IDRC investigators from Indiana University
School of Medicine (IUSM) and its affiliated institutions, working closely with members to provide “wrap-
around” services that include assistance with experimental design, efficient execution of experiments, and
assistance with data analysis and interpretation. The Core serves both experienced as well as novice users
and functions as an important conduit for facilitating entry into the field for investigators who have not
traditionally worked with islets or performed metabolic research. In addition to consultative and experimental
services, the Core provides training for investigators who wish to incorporate specialized techniques back into
their own lab. The Director of the Core is Dr. C. Evans-Molina, the Associate Director is Dr. S. Tersey, and the
Assistant Director is Dr. R. Anderson. The leadership is assisted by a crew of technical staff and advised by
an Advisory Board. The Core closely interfaces with the IDRC Translation Core, Microscopy Core, Systems &
Informatics Core, and Swine Core to meet the experimental needs of our user base, while also adhering to the
highest standards of rigor, reproducibility, refinement, and reduction. The Core will achieve the following aims:
(1) To provide IDRC investigators with high quality rodent islets and facilitate the procurement of
human and swine islets and pancreatic tissues for analysis.
(2) To provide state-of-the-art human, rodent, zebrafish and swine islet and pancreas characterization
services.
(3) To provide state-of-the art rodent metabolic analysis, including assessment of glucose and insulin
tolerance, body composition, energy expenditure, activity levels, and food intake.
(4) To provide consultation services and training that is tailored to fit the needs of both experienced
users and users who are new diabetes and metabolic research.
(5). To ensure that Core services evolve to meet IDRC investigator needs and keep pace with new
developments in the field